Reinvigorating the overdominant model of tumor suppression

Reinvigorating the overdominant model of tumor suppression
Tumor suppressor genes (TSGs) play essential roles in cancer pathogenesis, from cancer initiation to
progression and therapy responses. More than 50 years after Knudson proposed the “two-hit” model of tumor
suppression, this paradigm remains fundamental to the field of cancer biology and was later complemented by
the “one-hit” or haploinsufficiency model of tumor suppression. In contrast, a third mode of tumor suppression
posits a non-monotonic relationship between TSG dosage and tumor fitness, where inactivation of one gene
copy is beneficial, but the loss of both is less beneficial or even detrimental—a phenomenon due to genetic
overdominance. Utilizing CRISPR/Cas9-based somatic genome editing and tumor barcode sequencing (Tuba-
seqUltra), combined with gRNA cutting efficiency information, I identified seven candidate overdominant TSGs in
the oncogenic KRAS-driven lung adenocarcinoma, notably including Suz12 and Eed from the polycomb
repressive complex 2 (PRC2). In this proposed study, I hypothesize that overdominance is a significant factor
shaping the functionality of many TSGs and that overdominant TSGs are enriched in chromatin regulators. First,
I will refine the Tuba-seqUltra platform to systematically measure the overdominant effect of TSGs in vivo and
explore the interplay between different oncogenic backgrounds and overdominant tumor suppression (Aim 1).
To gain insight into the molecular mechanism of overdominant tumor suppression, I will investigate the
phenotypic consequences of heterozygous and homozygous deletion of the key PRC2 members Eed using
single-cell RNA-Seq and single-cell ATAC-Seq (Aim 2). Finally, to study the extent of overdominant tumor
suppression in lung adenocarcinoma, I will use machine learning methods to quantify the overdominance of 200
known and putative TSG. This will determine the prevalence of overdominance in tumor suppression and assess
whether overdominant TSGs are enriched in dosage-sensitive pathways like those involving chromatin
regulators (Aim 3). This study will establish robust methodologies for researching overdominant TSGs in cancer,
evaluating their prevalence, and deciphering the underlying molecular mechanisms. This could profoundly
impact our understanding of cancer biology and influence future therapeutic strategies.

Public health relevance
Project Narrative Lung cancer remains the leading cause of cancer-related deaths worldwide, yet our understanding of tumor suppressor loss in lung cancer is still limited. This project will combine advanced CRISPR-Cas9 techniques, sophisticated mouse models, and barcode sequencing innovations with comprehensive in vivo and molecular analyses to study the overdominant tumor suppression in lung adenocarcinoma. Understanding this specific mechanism of tumor suppression will be instrumental in developing more effective therapeutic strategies.